Clinical Research Training for Psychologists

Abstract
This program seeks to prepare clinical psychologists for scientific careers in a variety of
academic settings. Psychologists, who are well versed in psychological theory, experimental
methodology, and quantitative skills, possess talents that are critical for conducting clinical
research. Nevertheless, additional preparation is needed to enable psychologists to work
effectively on multidisciplinary teams, address current challenges in the field of mental health,
and compete successfully for independent research funding. Accordingly, in this competing
renewal application, we propose to continue and refine an existing, integrated program of
predoctoral and postdoctoral training for promising clinical psychological scientists. By recruiting
graduate students in clinical psychology who have demonstrated scholarly accomplishments,
we are uniquely positioned to identify and prepare talented psychologists for academic careers.
The specific aims are to provide trainees with: (1) intensive clinical experience with a broad
range of presentation seen in an academic medical center (during a year-long psychology
internship supported by our department); (2) a curriculum that enhances conceptual and
practical skills in clinical research, including instruction in the responsible conduct of research
and a focus on cultural humility in clinical science; and (3) an intensive postdoctoral research
apprenticeship supported by a mentorship team that includes established investigators. To
accomplish these training aims and in response to prior trainee feedback, we have established
a Diversity, Inclusion, Cultural Humility, and Equity (DICE) Initiative that permeates all aspects
of the training program. The program has a demonstrated record of recruiting strong clinical
psychology candidates and a sustained record of successful outcomes. Indeed, among the 16
fellows who have graduated from the program in the last 10 years,13 (81%) transitioned to
primary academic positions, 2 (13%) to individual postdoctoral training awards and 1 is in a
primary clinical position. Most (75%; n = 12) of these recent graduates have had external
research funding, with 8 (50%) competing successfully for NIH career development awards and
3 (23%) receiving support from NIH as principal investigators or co-investigators. Thus, our
program continues to achieve outcomes consistent with the mandate of institutional research
training grants: placement of graduates in academic positions, successful pursuit of
independent research projects, and sustained academic productivity. We are confident this
record of success will continue with additional funding.

Public health relevance
The goal of this training program is to train psychological clinical scientists to conduct research that will promote the scientific and training priorities of NIMH and enhance the public health. Clinical psychologists are well-qualified to promote the translation of research findings to the clinical setting in meaningful ways because they have been in the forefront of the development of efficacious treatments that incorporate evidence-based mechanisms associated with specific psychopathology. This training program seeks to capitalize on the unique foundational skill set of clinical psychologists and to further equip these scientists to make meaningful scientific contributions to enhance mental health across the lifespan.